Rapid Point-of-Care Assay for Diagnosis of Neurocysticercosis in Seizure Patients

Project Summary
Epilepsy, a disorder of the brain manifested by seizures, is the fourth most prevalent neurological disease,
affecting over 50 million people worldwide, or about 1 out of 150 individuals on average. The frequency of
epilepsy is distributed unevenly, however, with the vast majority of cases occurring in less developed regions of
the world. The likely explanation for this distribution is that one third of all epilepsy cases are due to
neurocysticercosis, known to be the most common parasitic infection of the nervous system. Neurocysticercosis
is caused by the presence of larval cysts of Taenia solium, the pork tapeworm, in the brain, which can cause
seizures and illness ranging from mild to fatal depending on their location, number and viability. In contrast to
idiopathic epilepsy, a complex disease which can be difficult to treat and resistant to cure, neurocysticercosis
can be treated and in many cases cured with inexpensive and available anti-helminthic drugs. Distinguishing
whether the cause of seizures is idiopathic epilepsy or neurocysticercosis is thus a critical part of the diagnostic
workup and essential to determine the appropriate course of treatment for patients. The established procedures
for diagnosing epilepsy comprise electroencephalography and imaging via MRI, but these sophisticated tools
are of limited availability in the less developed world where neurocysticercosis is most frequent. On the other
hand, neurocysticercosis can be diagnosed with a serological test that detects antibodies to T. solium cysts. The
gold standard serological test, the Enzyme Immunotransfer Blot (EITB) developed at CDC, is a laboratory-based
test, however, it is not widely available and requires significant training to carry out. Thus there is a critical need
for a rapid, commercially available point-of-care test for neurocysticercosis that can be used to test patients with
seizures, in order to identify those with the parasitic infection so that they can be treated effectively. Development
of such a test has been identified as an urgent priority by the World Health Organization.
In the Phase I project, we utilized recombinant and synthetic T. solium antigens corresponding to those used in
the EITB to develop a prototype lateral flow, point-of-care serological test for neurocysticercosis aimed at
meeting the criteria in the World Health Organization’s Target Product Profile. These antigens have shown high
sensitivity and specificity in prior studies, and in combination further increase the sensitivity for detection of single
viable cysts, the most challenging disease manifestation. In Phase II, the lateral flow neurocysticercosis test will
be evaluated in prospective studies on neurological patients with symptoms suggestive of neurocysticercosis,
and in retrospective studies on well-characterized sera from neurocysticercosis patients confirmed by EITB or
clinical diagnosis, and for specificity on healthy controls and other disease state sera. Phase II will support
complete development to commercial stage, clinical evaluation and preparation for CE mark and FDA
submission of the neurocysticercosis point-of-care test.

Public health relevance
Project Narrative Epilepsy is the fourth most common neurological disorder in the U.S. and affects over 50 million people worldwide. This project addresses the critical need for a point-of-care test to diagnose Neurocysticercosis in patients with epileptic seizures, as this parasitic infection is responsible for about one third of all epilepsy and is the major cause of adult epilepsy worldwide. In Phase II we will refine this assay into a manufactured product, carry out a validation study to support a de novo submission to FDA, and prepare for scale up and commercial launch of the assay.